Core B: Advanced Bioinformatics Core

PROJECT SUMMARY/ABSTRACT
CORE B – ADVANCED BIOINFORMATICS CORE
The Advanced Bioinformatics Core will provide innovative and collaborative computational support for all
three Projects, in close partnership with the Advanced Proteomics and Genome Editing Cores. We have
several decades of experience in developing statistics and bioinformatics methods for genomics and
proteomics, including open source software for analysis and visualization. For nearly 10 years, we have been
working closely with the Srivastava, Bruneau, and Black labs to dissect cardiac regulatory mechanisms using
the latest tools for data quantification and integrative analysis. These investigations identified several key
cardiac transcription factors and chromatin-remodeling proteins that can alter cardiac development and cause
CHDs when mutated. Yet we do not fully understand the mechanisms through which these regulatory proteins
function. It is clear from our preliminary studies that mutations alter their subcellular localization, protein
interactions, and genomic occupancy. New techniques in proteomics (e.g., APEX-MS) and genomics (single-
cell RNA-seq) promise to shed light on how these effects translate into disease phenotypes through altered
gene regulatory networks. But there are major challenges quantifying and jointly analyzing these diverse data
types. The objective of the Advanced Bioinformatics Core is to rule out chance, bias and confounding in the
data from Projects 1–3, using state-of-art analyses tools when available and developing new techniques
where needed. Our rigorous statistical approach will enable the Core to integrate data within and across
projects to decode novel mechanisms of CHD etiology that would otherwise be missed.